Discovering catalytic activities for pseudoenzymes

PROJECT SUMMARY
Numerous diseases stem from mutations or disturbances in enzyme activity. Comprehending the subsequent
impact on substrates could yield vital mechanistic insights into disease mechanisms, potentially paving the way
for interventions to treat these conditions. Most enzyme superfamilies contain catalytically inactive cousins
known as pseudoenzymes, which resemble enzymes structurally but lack catalytic activity. However, my
laboratory has discovered that some pseudokinases are catalytically active, catalyzing different chemical
reactions than their active counterparts. This challenges the notion that all pseudoenzymes are catalytically
inactive and suggests that they should be tested for alternative activities. Thus, a major goal of my research
program in the next five years will be to determine whether pseudoenzymes from various enzyme superfamilies
exhibit catalytic activity, potentially catalyzing novel chemical transformations.
Uncovering unexpected post-translational modifications (PTMs) for pseudoenzymes presents several
challenges. These include identifying candidate pseudoenzymes that are divergent members of the enzyme
superfamily, pinpointing the specific substrate(s) undergoing modification, and identifying the PTM itself. To
tackle these challenges, we have devised innovative strategies, including the development of a modular,
proximity ligation method called SidBait. SidBait is a robust and modular platform for uncovering protein-protein
and enzyme-substrate interactions. It has the potential to transform enzyme-substrate exploration, providing a
dependable and economical strategy for pinpointing targets. This innovation could substantially enhance our
understanding of enzyme and pseudoenzyme substrate interactions, increase the collection of recognized PTMs,
and yield crucial mechanistic insights into human diseases.
Importantly, pseudoenzymes are widespread in all major enzyme families throughout nature. Thus, assigning
catalytic activities to pseudoenzymes has the potential to make a major impact in the field and fundamentally
change the way we think about cellular signaling and regulation.
I have assembled a team of diverse,
enthusiastic, and dedicated trainees, which uniquely positions us to continue to make discoveries in this research
area. Therefore, I am confident that the research program I have developed will uncover new biology, potentially
leading to the development of innovative diagnostic tools or treatments for human diseases.

Public health relevance
NARRATIVE Uncovering activities for pseudoenzymes is crucial for understanding basic biological pathways and unraveling disease mechanisms. However, this is no simple undertaking and existing methods are less than optimal. We have developed innovative strategies, including the development of new technology that enables efficient pseudoenzyme substrate identification, and we aim to leverage this innovation to uncover novel insights in the realms of human health and disease.